Center for Population Health Research

Summary Overall, Center for Population Health Research
Rural populations suffer disproportionately from several disease burden and risk factor exposures that
adversely impact quality of life, but most health promotion and disease prevention strategies are developed
and tested in urban settings. Montana is within the top five most rural states in the US and the most rural state
in the West region, according to the proportion of total population residing in rural communities. The Center for
Population Health Research (CPHR) was established to improve health outcomes and quality of life among
rural and other vulnerable populations in our state. During initial years as a Center of Biomedical Research
Excellence (COBRE), CPHR achieved substantial success by mentoring and supporting early stage
investigators (ESIs) that went on to obtain substantial extramural grant funding, growing our critical mass of
investigators through pilot project funding and new hires, and establishing robust research cores designed to
meet the needs of our research team. Our overall objective with this Phase 2 COBRE application is to further
strengthen our successful Center through continued development of ESIs that add to our critical mass of
population health researchers and to further enhance our research support cores, altogether translating to a
sustainable, impactful Center. To accomplish our overall objective for this Phase 2 COBRE we will pursue the
following strategies. First, we will continue to identify, mentor, and develop ESIs that will include: (a) three
continuing ESI research project leads (RPLs); (b) two new ESI RPLs; (c) a pipeline of Pilot Project Leads
(PPLs); (d) new hires; and (e) the larger community of Montana investigators affiliating with CPHR and the
culture of success that we foster. Second, we will continue to strengthen CPHR Cores by providing guidance,
expertise, and innovative tools to support the Center long-term goal. The Administrative Core provides grant
support, professional development and mentoring support, and a pilot projects program. The Data and
Modeling (DM) Core provides biostatistical consulting, sensitive data curation, and high-performance
computing. The Intervention Support (IS) Core provides support for community engagement and primary data
collection, including participant recruitment, clinical measures, survey support, and qualitative methods. The
two research support cores continue to build their user base, implement business plans, and add innovative
features in Phase 2 that are driven by the needs of the growing pool of CPHR ESIs. Upon completion of the
proposed Phase 2 COBRE, CPHR will have a growing number of extramurally-funded population health
researchers in early, mid, and senior career phases. Collectively, these efforts will generate evidence-based
strategies and tools to improve health outcomes in the state’s rural and vulnerable populations.

Public health relevance
Project Narrative The long-term goal of the Center for Population Health Research (CPHR) is to build a sustainable Center that serves as a home for mentoring and supporting early career researchers that are investigating and developing solutions for disease burden in rural and other vulnerable populations in Montana. Mentoring, administrative support, and research core tools and expertise will yield a growing number of extramurally-funded population health researchers in early, mid, and senior career phases. Collectively, CPHR efforts will generate evidence- based strategies and tools to improve health outcomes among the state’s rural and vulnerable populations.